American Society of Neurorehabilitation (ASNR): 2018 Annual Scientific Meeting

R13 Conference Grant for 2018 ASNR Annual Meeting Winstein, C Summary (Abstract) The 2018 American Society of Neurorehabilitation (ASNR) conference is planned for November 1-2 in San Diego CA, as a pre-meeting unofficial satellite of the Society for Neuroscience annual meeting (SfN). The mission of the ASNR is to promote the medical and social wellbeing of persons with disabling neurological disorders, to advance training and research in the basic and clinical sciences that can lead to functional recovery of neurologically impaired persons, and to disseminate the knowledge of this research among professionals and the general public. Our annual meeting provides interactions among neurorehabilitation clinicians, basic scientists, industry representatives, foundations and funders in a dynamic environment of presentations and lively discussions. The ASNR has the advantage of attracting a broad audience of research-oriented clinician-scientists representing a diverse group of professionals (e.g., MD, PT, OT), many with dual academic and professional degrees (e.g., MD, PhD), as well as neuroscientists deeply interested in translational work. Based on the four previous years, we expect between 200 and 300 attendees, both professionals and trainees from the disciplines described above. In 2017 we added a half-day pre- conference (on the topic of Neurorehabilitation Device Development) to the proven and successful two-day conference program format. The two-and-a-half day format will serve as the model for the proposed 2018 conference program. This single-track format featured five Symposia, two Poster and Exhibit sessions (1/day), 1.5 hr awards ceremony including two special lectures and the now high- profile closing session, Controversies in Neurorehabilitation. This R13 application requests $10,000 to support travel awards for up to four diversity fellowships, publication costs for the conference brochure, name tags etc., support to defray registration fees for attendees and speakers, travel for special attendees and outside speakers, up to three poster awards for student and postdoctoral/fellow investigators and approximately 10% of the total audio-visual cost for the symposia.

Public health relevance
R13 Conference Grant for 2018 ASNR Annual Meeting Winstein, C Narrative (Public Health Relevance Statement) The 2018 American Society of Neurorehabilitation annual conference is to be held as a pre-meeting unofficial satellite of the Society for Neuroscience meeting (SfN). Throughout its history, the ASNR annual conference has been one of the very few scientific meetings that inclusively and uniquely encompasses multiple disciplines of clinicians and researchers all of whom have an intense interest in translational work that connects the scientific basis of neural repair and recovery to the promotion of health and well-being in the process of recovery and beyond for a variety of devastating neurological conditions (e.g., stroke, spinal cord injury, traumatic brain injury, cerebral palsy) including neurodegenerative diseases (e.g., Parkinson’s Disease, multiple sclerosis, amyotrophic lateral sclerosis).